Cell-Wall Recycling and Antibiotic Resistance

Project Summary/Abstract Enterobacteriaceae and Pseudomonas aeruginosa (subject of this grant application) sense damage inflicted to their cell wall by β-lactam antibiotics. The sensing event is linked to cell-wall recycling, which generates cell- wall-based natural products known as muropeptides. Certain internalized muropeptides induce antibiotic resistance mechanisms. This process has led to obsolescence of many of the β-lactam antibiotics against Gram-negative bacteria. These complex events are poorly understood, and are the subject of study in this grant proposal. Two Specific Aims are proposed. I propose to study the periplasmic complexes involving lytic transglycosylases (LTs), which turn over the cell wall for the purpose of recycling, in Specific Aim 1. We have documented that there are 11 LTs in P. aeruginosa, whose individual reactions on the cell wall are described in this grant application. These enzymes are proposed to be involved in complexes with other proteins within the periplasm, whose identities are not known and represent a major gap in our knowledge of cell-wall processes. Whereas all the functions of LTs are not understood, one would appear to be repair of cell wall upon exposure of bacteria to β-lactam antibiotics. Bulgecin A, a natural product inhibitor of LTs, was shown to potentiate the activity of β-lactam antibiotics. This takes place as bulgecin A impairs the function of the LTs. Specific Aim 2 proposes to study bulgecin A and its derivatives by a detailed microbiological and enzymological evaluation of the compound. I anticipate that the successful completion of this proposed science will not only lead to the elucidation of these important events regulating the cell wall, but also will identify opportunities for their interruption as a means to circumventing the elaborate mechanism of β-lactam resistance that Gram-negative bacteria have evolved. The needs for novel strategies in treating Gram-negative bacterial infections have never been as accute within the past 50 years. The use of combinations of bulgecin A (or a variant thereof) and β- lactam antibiotics holds a great promise, which deserves to be investigated.

Public health relevance
Project Narrative Bacteria become progressively resistant to all existing antibiotics, rendering them obsolete. Gram-negative bacteria are among the most notorious human pathogens that have evolved a host of resistance mechanisms. These are among the most difficult pathogens to treat clinically. These bacteria have evolved an inducible mechanism for resistance to β-lactam antibiotics (such as penicillins, cephalosporins, carbapenems, etc.) as an offshoot of the physiological processes of cell-wall recycling. The mechanism is complex and the outcome of resistance to a broad range of antibiotics is disconcerting. The needs for novel strategies in treating Gram-negative bacterial infections perhaps have never been as urgent within the past 50 years. The study of these processes is the mission of this grant application. It is our expectation and hope that these studies will pave the way in devising stategies to overcoming these clinical difficulties.